Vision Training Grant

ABSTRACT
This is an application for continued funding for the Vision Training Grant (VTG) at the University
of Washington (UW) which includes 27 preceptors in six Departments and four
Interdepartmental Programs. Our goal is to train the next generation of independent vision
scientists to communicate and access techniques broadly across vision sub-fields, and to
appreciate the links between fundamental and clinical research with the aim of developing
treatments for diseases of the visual system. Funds are requested to provide training for four
pre- and two post-doctoral trainees in the effective communication of scientific principles to a
broad audience, in grant-writing as a pathway to independence, and to provide exposure to a
broad range of topics and techniques in vision research ranging from individual proteins and
molecules to systems-level neuroscience and cognition. Trainees are required to attend a
weekly journal club where, each week, preceptors discuss an influential paper in their sub-field.
Trainees will also participate in monthly lunches where a wide variety of topics including ethics
and alternative career options will be discussed. Trainees will present their work twice each
year--once as a talk at an annual symposium for VTG trainees, and another as a poster at the
“Gained in Translation” Vision symposium, attend VTG seminars and participate in VTG lunches
with the visiting speaker, prepare an independent grant for submission and participate in training
for responsible conduct of research. Postdoctoral trainees are also required to participate in “Hit
the Ground Running”, a mentoring program for postdocs. Trainees will also receive mentorship
related to the successful completion of research projects and options for alternative careers.
Predoctoral trainees will be supported for two years and postdoctoral trainees for one year. The
Vision Training Grant is currently the only source of support for pre- and post-doctoral trainees
who want to commit to biomedical research in Vision and Ophthalmology.

Public health relevance
NARRATIVE PUBLIC HEALTH RELEVANCE: Basic and clinical research can be expected to have a dramatic and constructive impact on visual disabilities, one of the highest priorities for improved world health. The Vision Training Grant at the University of Washington supports research and education of young scientists who will make the next generation of advances to conquer biomedical problems in vision and ophthalmology. The opportunities for vision training at the University of Washington are multidisciplinary and cover a broad spectrum of disciplines from cellular and molecular biology to systems biology, visual perception and computational neuroscience. We welcome the opportunity to contribute new solutions to help decrease blindness and morbidity in the world.